Administrative Core

PROJECT SUMMARY: ADMINISTRATIVE CORE
The Administrative Core provides support for the management of the Center Core Grant by coordinating and
integrating activities of individual resource Cores. The main goal of the Administrative Core is to maximize the
effectiveness and impact of the Core Grant for advancing vision science research. It provides an
organizational infrastructure for optimized coordination, integration, and evaluation of Core activities. It
ensures and promotes accessibility and beneficial utilization of Core resources by all participating
investigators.

Public health relevance
NARRATIVE: ADMINITRATIVE CORE The Administrative Core provides support for the management of the Core Grant by coordinating, integrating, and evaluating activities of the individual resource Cores.